Testing Surgery Guided by Molecular Fluorescence Imaging

DESCRIPTION (provided by applicant): This proposal describes a 5 year training program for the development of academic career in Surgery. The principal investigator has completed a combined M.D./Ph.D. program at the Washington University and an ACGME accredited residency training program in Otolaryngology-Head and Neck Surgery at the University of California San Diego (UCSD). She has also completed a postdoctoral fellowship in Skull Base Surgery at UCSD and now, will expand her combined training in clinical medicine and scientific research through an unique integration of interdepartmental expertise and resources. Dr. Roger Tsien will mentor the principal investigator's scientific development. Dr. Tsien is a recognized leader in the field of cell biology and neurobiology and is world renowned for developing colorful fluorescent dyes for monitoring intracellular processes. He has been a Howard Hughes Investigator since 1989, is a Professor in the Dept of Pharmacology at UCSD and has trained numerous postdoctoral fellows and graduate students. To enhance the training, the program will also have an advisory committee of physician scientists who are leaders in their fields and who will provide scientific and career advice. Research will focus on the development of an animal model for molecular fluorescence guided surgery. The specific aims include 1) develop an imaging system for fluorescence guided surgery in small animals, 2) develop animal models for fluorescence-guided surgery, with quantitative objective criteria for accuracy of excision 3) develop animal models for whole body imaging coupled with fluorescence image guided surgery Despite recent technological advances in the noninvasive diagnosis of cancers including CT, MRI and PET imaging, the main treatment modality for solid malignant tumors is surgical excision. However, surgical excision of tumors remains dependent on the individual surgeon's ability to differentiate tumor from normal tissue using non-quantifiable criteria such as tumor location, texture, color, relationship to surrounding structures etc. The relevance of this project is to provide the operating surgeon with a sensitive molecular marker visualizable in real time to differentiate tumors from non-tumor tissue intraoperatively, thereby guiding surgical excision.